Dichotomy of Phosphate Actions in Periodontal Health

Phosphate (PO43-/Pi) is a natural component of animal and plant food sources and is widely used as food
additive in the modern Western diet. With the high consumption of processed foods, the average dietary Pi
intake greatly exceeds the body requirements and recommended dietary allowance in the United States. The
pathological consequences of the dietary Pi overload include inflammation and disrupted bone metabolism. On
the other hand, Pi insufficiency, either systemic or at the cellular level, results in impaired formation of skeletal
and dental tissues. Pi is a signaling molecule that changes cellular physiology. This function of Pi depends on
levels of available Pi, but outcomes depend on a type of a cell exposed to Pi, that is on its molecular makeup
and transcriptional program. In vitro studies from our and other labs implicate GATA-type transcription factors
in regulation of gene expression in response to Pi. We have shown that Trps1 (a GATA-type transcription
factor) is critical for recognizing and responding to available Pi in cells producing mineralized extracellular
matrix. Importantly, our published and preliminary data also revealed that Pi regulates the activity of this
transcription factor suggesting that Pi and Trps1 form a regulatory loop controlling gene expression in skeletal
and dental tissues. The goal of the proposed study is to determine the interplay between dietary Pi availability,
its pro-osteogenic and pro-inflammatory effects and the Trps1-regulated formation and homeostasis of the
periodontium. Periodontium is a multi-tissue structure that anchors the tooth to the jaw bone and provides a
barrier protecting the underlying tissues from the oral microbiota. At least two of the periodontal tissues
(cementum and bone) depend on adequate Pi availability, which is highlighted by increased susceptibility and
severity of periodontal disease in individuals with Pi deficiency. Periodontal disease is a highly prevalent
inflammatory condition affecting at least 2 in 5 adults aged 45−64 years in the United States. Our preliminary
data from Trps1Col1a1 cKO mice detected periodontal defects characteristic for Pi deficiency, further supporting
the involvement of Trps1 in cellular responses to Pi. Hence, we hypothesize that the interplay between the Pi
availability and Trps1-regulated bone and cementum development maintains the homeostasis of periodontium.
We will address this hypothesis through a set of in vivo experiments that will: 1) determine the effects of dietary
Pi intake on Trps1 activity in osteoblasts and cementoblasts; 2) define the relationship between the dietary Pi
intake and the Trps1-dependent formation of the cementum and alveolar bone; 3) determine the
consequences of the dietary Pi overload on sound and genetically compromised periodontium in the context of
disrupted periodontal homeostasis. Results of these studies will provide the understanding of the differences
between healthy and impaired alveolar bone responses to Pi availability and inflammatory challenge, which will
facilitate development of preventive and therapeutic strategies aimed at improving periodontal health in
individuals with genetically impaired periodontal structure.

Public health relevance
NARRATIVE The importance of the appropriate phosphate availability for the periodontal health is highlighted by skeletal and dental pathologies caused by phosphate deficiency, and inflammatory responses caused by high dietary phosphate intake or high systemic phosphate levels. This project investigates the interplay between the dietary phosphate intake and genetic factors regulating the response to this ion and formation of mineralized tissues in the context of periodontal development and homeostasis. Results of these studies will provide new knowledge that will facilitate designing the preventive and therapeutic strategies aimed at improving periodontal health in individuals with genetically impaired periodontal structure.